Midcareer Mentoring Award for Patient-Oriented Research in Aging

PROJECT SUMMARY/ABSTRACT The aims of this proposal are to (1) enable the candidate to further develop her research program focused on improving cancer screening and prevention in older adults and (2) use her research program as a platform for mentoring junior patient-oriented investigators interested in aging research, both within Geriatrics and within the medical subspecialties. The candidate is a Geriatrician who has established a high-impact independent clinical research program that is well funded with an outstanding publication record. In the 10 years since completing her Geriatrics fellowship she has established herself as a successful mentor of students, fellows, and junior faculty who have published high-impact aging research, become successfully funded, and continue to participate in patient-oriented research in aging. The candidate has developed an extensive research portfolio focused on the outcomes of cancer screening in elders that has sought to improve the targeting of cancer screening by better defining the risks and benefits, particularly as a function of life expectancy. This work has influenced screening guidelines in the U.S., which have used this research to recommend that screening decisions focus more on life expectancy than chronological age and better recognize the potential harms of screening. This proposal will provide the candidate with protected time to expand her research in a new direction focused on surveillance testing for cancer recurrence in older cancer survivors. Surveillance in older cancer survivors poses similar issues to screening in that it can potentially benefit elders by finding recurrent cancers when still treatable but also may cause substantial morbidity through overtreatment. The research in this proposal will inform decision making in this area by better defining the risks and benefits of surveillance testing in older prostate cancer survivors. This new direction maintains her research focus while building new collaborations with oncology. The candidate will also develop a formal mentoring program with plans for the recruitment, selection, development, and evaluation of mentees who will become leaders in aging research. Each mentee will have a focused career development plan in which they complete research projects and develop the skills needed to become independent investigators in aging research. This proposal integrates the candidate's mentoring program into the outstanding clinical research training environment at UCSF, leveraging her leadership positions in the Division of Geriatrics and the Clinical and Translational Science Institute (CTSI) Career Development (KL2 Scholars) Program to recruit more mentees interested in aging research.

Public health relevance
PROJECT NARRATIVE This proposal will have unique public health importance because (1) it will increase mentoring of new clinical investigators interested in conducting research to improve care for the rapidly growing elderly population, and (2) it will inform national guidelines and clinical decision-making by better defining the risks and benefits of prostate-specific antigen (PSA) surveillance practices in elderly prostate cancer survivors. __SpecificAimsTextDelimiter__ I. SPECIFIC AIMS Major contributions of Dr. Walter's prior research have been to develop and apply a novel conceptual model for screening decisions in older adults which demonstrated the fundamental importance of life expectancy rather than age limits in cancer screening. Dr. Walter's work has influenced screening guidelines in the U.S., which have used her research to recommend that screening decisions focus more on life expectancy than chronological age and better recognize the potential harms of screening. Over the next 5 years Dr. Walter plans to extend her research in several ways, including the conduct of 1) currently supported research to quantify the downstream consequences of cancer screening in older adults according to life expectancy, and 2) new research to be supported by this K24 to determine the use and outcomes of surveillance testing for cancer recurrence in older adults who have survived seemingly curative therapy. Dr. Walter's currently supported research includes a VA IIR to determine the use and outcomes of colorectal cancer screening in older adults and an NCI R01 to determine the use and outcomes of prostate cancer screening in older men. Currently, there is a lack of "real world" data quantifying the long-term downstream consequences of cancer screening and how these consequences differ according to life expectancy. These "real world" data are fundamental to enhancing screening guidelines and decision- making for older adults and to informing areas of controversy leading to policy changes (See Section J.1). For the new research to be supported by this grant, Dr. Walter will develop an innovative new direction focused on surveillance testing for cancer recurrence in older cancer survivors. Surveillance testing poses similar issues to screening in that it can potentially benefit elders by finding recurrent cancers when still treatable but also may cause substantial morbidity through overtreatment. This new research direction will build collaborations with oncology and expand and enrich her research and mentoring programs while maintaining her focus on improving cancer prevention strategies in older adults. For this proposal, Dr. Walter will study surveillance practices and outcomes in older prostate cancer survivors because this builds directly on her currently funded R01, which makes the study feasible with the resources of the K24 and the data will be more immediately accessible as a platform for mentoring new clinician investigators in POR. The importance of studying prostate cancer surveillance testing is evidenced by the rapidly growing number of older men living years after treatment for prostate cancer and the lack of data about prostate specific antigen (PSA) surveillance practices and outcomes. While guidelines provide recommendations about the frequency of PSA testing to monitor for cancer recurrence, evidence supporting surveillance guidelines is limited. Randomized trials of PSA surveillance practices do not exist, and we also lack national "real world" data quantifying the use and outcomes of surveillance testing in older prostate cancer survivors. For example, it is not known how often surveillance PSA testing is performed in older men and how often it leads to repeated biopsies, treatment, and treatment-related complications. These "real world" data are fundamental to informing the decision-making process and PSA surveillance guidelines for older men. This proposal makes innovative use of national VA clinical data, VA and Medicare claims-based data and electronic health records to provide novel and clinically relevant information on the determinants and downstream outcomes of PSA surveillance testing in older men across a spectrum of life expectancy and cancer characteristics. The specific aims of this project are as follows: Aim 1: To determine the frequency of PSA surveillance testing and its association with age, comorbidity, and cancer characteristics (e.g., stage, Gleason score, PSA level) among men aged 65 years or older who have survived curative treatment (e.g., prostatectomy or radiation) for clinically localized prostate cancer. We hypothesize that rates of PSA surveillance testing will be similar among older men regardless of life expectancy or cancer characteristics because guidelines recommend surveillance testing regardless of risk of recurrence. Aim 2: To describe the outcomes of PSA surveillance testing (e.g., elevated PSA, biopsies, imaging, cancer diagnoses, treatment, complications, and survival) during the 5 years after curative treatment for localized prostate cancer among men aged 65 years or older across a spectrum of life expectancy. We hypothesize that PSA surveillance testing in older men with limited life expectancies will frequently necessitate workup that leads to burden rather than benefit.